Cherokee NARCH Administrative Core

Abstract
The Administrative Core of Cherokee Nation Native American Research Centers for Health (Cherokee
NARCH) provides the organizational hub for the jointly conducted student career enhancement, capacity
building, and research/pilot research projects that comprise Cherokee NARCH. Cherokee NARCH is novel, yet
complex, as it includes alliances with universities that train amongst the largest numbers of American Indian
students in the United States. To address this complexity, the Administrative Core establishes shared
leadership between the participating institutions, a Tribal/Campus Advisory Committee, and processes and
procedures for regular communication and decision making among the Cherokee NARCH partners. The
research, capacity building, and training activities of Cherokee NARCH are integrated and mutually reinforcing,
with the ultimate goal of providing Cherokee Nation with the capacity to pursue independent research to
address tribal health disparities. The Administrative Core specific aims are to: 1) provide joint leadership and
infrastructure to ensure effective operational oversight; 2) conduct rigorous planning and implementation
processes for all Cherokee NARCH projects; 3) conduct program evaluation to gauge overall success of
Cherokee NARCH; 4) and pursue funding to ensure sustainability of our efforts to increase research capacity
at Cherokee Nation. A major goal of Cherokee NARCH is to build the foundation for future tribally engaged
cancer research. The Administrative Core proposed herein is essential to this effort, as it ensures that all
aspects of the program are integrated into a collaborative effort addressing health disparities and research
needs for Cherokee Nation.